Ending the HIV Epidemic in Rural America (EHE-RA): Local Interventions, Co-Epidemics, and Social Determinants

SUMMARY:
Despite advances in treatment and prevention over the past decades, human immunodeficiency virus (HIV)
imposes substantial burdens in the United States (US). US HIV infections are increasing concentrated in
Southern states with a disproportionate number of rural infections, particularly among racial, ethnic, and sexual
minorities. Rural epidemics in these states are linked to high-intensity urban epidemics, and driven by
racial/ethnic disparities, poverty, inadequate insurance, limited access to healthcare, and housing insecurity.
Additionally, the opioid epidemic disproportionately affects rural communities, increases HIV transmission, and
hinders HIV control efforts.
The Ending the HIV Epidemic (EHE) Initiative seeks to reduce HIV incidence by 90% over a decade. Ending the
US HIV epidemic will require interventions tailored to local-level epidemic dynamics that address underlying
drivers of transmission. Mathematical models of HIV transmission are powerful tool to forecast epidemics, and
can provide evidence-based guidance on the optimal way to prioritize limited public health resources, but these
models have focused primarily on urban epidemics. We have previously developed the Johns Hopkins
Epidemiologic and Economic Model (JHEEM), a platform for modelling local HIV epidemics.
Our objective is to generate projections of local HIV epidemics in states with a high rural burden of HIV to inform
policy decisions by local health departments. We will partner health departments in three states where we have
established relationships (Alabama, Louisiana, and Mississippi) to develop a suite of transmission models, based
on JHEEM, that rigorously leverage local surveillance data to make projections of the HIV epidemic in each state.
In Aim 1, we will develop an integrated, statewide modeling approach that links rural and urban regions using
mobility data. We will use the models to identify which combinations of HIV testing, pre-exposure prophylaxis
(PrEP), and viral suppression – targeted to which demographic subgroups and geographic regions – will yield
the greatest reductions in incidence and disparities. In Aim 2, we will incorporate three social determinants of
health: insurance, access to healthcare, and housing instability, and the racial and ethnic disparities in their
distribution across the population. We will project the impact on HIV incidence and disparities of strategies that
include both traditional HIV interventions and increase insurance, access to care, or stable housing. In Aim 3,
we will expand JHEEM to include the opioid epidemic, and evaluate the potential reductions in HIV incidence
achievable by strategies that combine harm reduction for opioid use disorder with HIV control interventions.
These aims will yield a comprehensive modeling framework that links traditional HIV interventions with underlying
drivers of the epidemic in rural America. Our results will provide data-driven projections, tailored to the specific
needs of states, to inform effective deployment of public health resources in ending the HIV epidemic.

Public health relevance
NARRATIVE: Reducing human immunodeficiency virus (HIV) infections in the US, which are increasingly concentrated in Southern states with a large rural HIV burden, will require interventions tailored to local-level epidemic dynamics that address racial and ethnic disparities and underlying drivers of transmission. We will partner with three state health departments where we have established relationships (Alabama, Louisiana, and Mississippi) to develop a suite of HIV transmission models that link rural and urban region and incorporate insurance, access to health care, housing instability, and the opioid epidemic. These models will project the likely impact of interventions that address HIV as well as social determinants of health and opioid misuse, to fill an urgent, unmet need for evidence-based guidance in prioritizing local interventions in the service of ending the HIV epidemic in states with a large rural burden of HIV.